Forward Genomics of Damage Control: An Undiscovered Class of Cancer Genes

DESCRIPTION Abstract An Undiscovered Class of Cancer Genes ABSTRACT The central hypothesis of this project is that there exists a large, highly-conserved class of genes/proteins that regulate levels of spontaneous DNA damage in all living cells, and so are the proximal, upstream effectors/modulators of genome instability. These are proposed to include many highly conserved essential genes that, in humans, are expected to constitute a "new" class of cancer genes distinct from (upstream of) the two main recognized classes: genomic-caretaker and gatekeeper genes. However these "damage-control" genes/proteins have remained undiscovered and unrecognized because of two limitations. First, no technology existed to assay spontaneous/endogenous DNA damage, particularly DNA breakage, directly in living cells. Thus, factors that affect the levels of endogenous DNA damage have mostly not been assayed, and not considered. Second, many of the damage-control genes are likely to be essential for organism viability, and current forward-genetic approaches in model organisms, which might otherwise have found some of these genes, are biased against essential genes. We expect the damage-control genes to encompass at least the following: (1) normal metabolic pathways (carbon metabolism, etc.) that unavoidably produce toxic by-products that react with DNA causing base/nucleotide damage;(2) proteins/molecules that scavenge these by-products;(3) DNA replication components. (DNA breaks often result from replication into damage.) All of these are expected to be very highly conserved because they are so basic to life, and most are expected to be essential genes. The goals of this project are--(1) to develop a new methodological paradigm of forward genomics that will allow rapid identification of genes, including essential genes, of interest to any problem in biology;(2) using this paradigm, to find the damage-control genes in the simple model organism E. coli, identify their counterparts in human, then id

Public health relevance
In this project, it is proposed that a large and important class of genes exists universally in all organisms, and that, in humans, these genes constitute a new class of cancer genes. These genes were not previously hypothesized or identified, in part because of inadequate genetic methods for finding and understanding them. The project proposes the development of new methods capable of finding and defining the functions of these genes (and of many other classes of genes that have eluded conventional strategies). The project uses these new methods to find and learn the functions of the proposed new cancer genes. Understanding these genes is likely to improve cancer treatment, diagnosis and prevention strategies.